Advancing Mass Spectrometry Analyses of Proteins, Assemblies, and Proteoforms

PROJECT SUMMARY/ABSTRACT
Understanding cellular processes and pathways in depth requires methods that not only investigate the
composition and arrangement of various protein assemblies, but that also elucidate their dynamics and
functional regulation. Experimental strategies delivering structural information beyond primary sequence; i.e.,
higher-order structure and protein modifications, connect proteomics to structural biology in ways yielding
potential insights into complex disease mechanisms. New techniques based on mass spectrometry (MS),
native MS (i.e., measuring biomolecules in their native solution environment preserving ligand- and other
molecular interactions), and top-down MS/proteomics will be advanced and applied to facilitate the
characterization of proteins and protein assemblies. Coupling sensitive ionization, solution- and gas-phase
separations, new electron-based dissociation methods (e.g., electron capture dissociation, ECD; electron
ionization dissociation, EID) and other activation/dissociation techniques to ultra-high resolution mass
spectrometry will provide an experimental platform for complete sequence and proteoform coverage. These
advanced tools will be employed to characterize important biological complexes for which high-resolution
structures have been difficult to obtain, including G-coupled protein receptors (GPCRs) and other membrane
proteins. The exploration of links between post-translational modifications (PTMs) and proteoforms to the
aggregation and toxicity of neurodegenerative diseases such as Alzheimer's disease (AD) will be furthered by
our advanced MS methods. Our experimental strategies apply broadly and integrate with numerous
biophysical techniques to enable the detailed structural study of large and complex molecular machines and to
provide insights into their dynamics. Native top-down MS promises to advance structural biology and to hasten
drug discovery and development. Improvements in MS-based technologies can advance our understanding of
how proteins and protein machines drive biology.

Public health relevance
PROJECT NARRATIVE We aim to develop robust analytical technologies that can provide structural information for biologically important proteins and molecular machines, such as those involved in neurodegenerative disorders and aging (e.g., Alzheimer’s disease). New methodologies to elucidate the sites of protein modifications will be developed, with the knowledge gained on modification sites to be used to enhance our understanding of the cellular mechanisms for a range of biological processes, including Alzheimer's disease. This is a particularly pressing goal in view of the rapid aging of our nation’s population and the rising costs of care for patients with neurodegenerative diseases.